Examining the crossover effects of adolescent stress on parent cardiovascular health

Project Summary
Cardiovascular disease (CVD) is one of the leading causes of death in the US that disproportionally affects
minorities and low-income individuals. The risk for and course of CVD is affected by social factors such as
daily stressors (i.e., interpersonal conflicts and demands). Daily stressors and strong reactivity to stressors
(stronger affective responses to daily stress) are strong predictors of CVD and two risk factors for
CVD: higher cardiometabolic risk and inflammation. One central source of daily stress during midlife is
parenting, and many parents and their children report increased stress during adolescence. The daily
stressors of adolescents can crossover to affect the health of their parents. Our preliminary studies have
found that on days when adolescents experience stressors, their parents are more likely to experience
negative affect, physical symptoms (i.e., headaches, flu-like symptoms), and unhealthy physiological
responses to stress (i.e., high cortisol) that same day. However, little is known about how adolescent stress
can crossover to affect their parents’ long-term CVD risk. Such knowledge is critical given that adolescent
stress may be a driver of poor parent health and developing interventions to interrupt crossover
processes may be an important avenue to reduce parents’ risk for CVD. In this study, we test the
associations between adolescent daily stressors and two risk factors for their parents’ CVD: parent
cardiometabolic risk and inflammation. We use three unique samples of parent-child dyads (n=718) with
different demographic profiles to (a) test if our findings are replicable on different populations and (b)
identify important socioeconomic (SES), racial, ethnic, and sex disparities in the crossover effects of
adolescent stress on parents’ CVD risk. Using both secondary data and new primary data collection, in Aim 1
we identify the crossover effects of adolescent stress on parent health by testing whether (a) adolescent daily
stressors (stressor exposure, severity, emotional responses) and (b) parent reactivity to adolescent stressors
predict parent cardiometabolic risk and inflammation concurrently and longitudinally. In Aim 2 we identify the
psycho-cognitive (psychological distress, worry, perseverative thinking), social (parent-child warmth and
conflict, parent loneliness), and behavioral factors (sleep) that mediate the crossover effects of adolescent
daily stressors on parent cardiometabolic risk and inflammation. In Aim 3 we identify health disparities by
testing whether the associations tested in Aims 1 and 2 are moderated by parent socioeconomic status, race,
ethnicity, and adolescent biological sex. Public Health Impact: This project will identify (a) how adolescent
stress impacts parent cardiometabolic risk and inflammation, (b) the modifiable psycho-cognitive, social, and
behavioral mechanisms underlying these associations, and (c) socioeconomic, racial, ethnic, and sex
disparities in these processes. Findings will lead to the design of a future parenting intervention to help parents
respond to adolescent stress in ways that promote parent health.

Public health relevance
PROJECT NARRATIVE Public Health Impact: Daily stressors and demands are associated with increased risk for cardiovascular disease and yet little is known about how the daily stressors experienced by adolescents can crossover to affect the health of their parents. This project will identify (a) how adolescent stress affects two risk factors for their parents’ cardiovascular disease: parent cardiometabolic risk and inflammation, (b) the modifiable psycho- cognitive, social, and behavioral mechanisms underlying these associations, and (c) socioeconomic, racial, ethnic, and sex disparities in these processes. Findings will lead to the design of a future parenting intervention to help parents respond to adolescent stress in ways that promote parent cardiovascular health.